West Virginia University Stroke COBRE

The Overall Objective of the WVU Stroke CoBRE is to decrease morbidity and mortality related
to stroke through improved understanding of pathophysiological mechanism(s) of stroke. We will
accomplish this overall goal by conducting high-quality basic and translational research
addressing the modifiable risk factors, biomarkers, mechanism(s), preventative strategies, acute
and chronic treatments and rehabilitation of stroke. This objective would be met by achieving the
following three Specific Aims: Specific Aim 1. Expand the critical mass of funded investigators
conducting stroke recovery research. In Phase II we propose to solidify the commitment of
investigators to stroke research, in part, by providing cutting-edge stroke research core facilities
and services (See Specific Aim 2), generating meaningful preliminary data in support of their grant
applications through funding of five Junior Investigator projects, providing grantsmanship
workshops/activities to improve their grant applications, and expanding the intensive mentoring
program initiated in Phase I of the WVU Stroke CoBRE. Specific Aim 2. Strengthen innovative
scientific cores that support and advance basic and translational stroke research. We propose to
expand the scope and capacity, as well as the user-base of these vital cores. This will be
accomplished by the introduction of new services (e.g., new stroke models; additional behavioral
tests), and provide training sessions for research cores. In addition to the Experimental Stroke
Core (ESC) and the Rodent Behavior Core (RBC), which are proposed for CoBRE funding, we
will develop two additional cores, the Mitochondrial Functional Assessment Core (MFAC) and the
Stroke Tissue Bank. Specific Aim 3. Advance the ongoing development of an independent,
sustainable, multidisciplinary thematic program of research on stroke. The goal of achieving
independences (of CoBRE funding) of the WVU Stroke CoBRE has begun and will continue in
Phase II by the transition to a user-fee based funding of research core services, the independent
funding of research grants that include funding for these core services and support from the WVU
HSC. At the conclusion of Phase II of the WVU Stroke CoBRE, mentored training will have
been provided to engage additional JIs in stroke-related research. We will have addressed the
need for basic and translational research into the causes, acute and subacute treatments and
recovery from stroke by (1) increasing the number of independently funded WVU stroke
researchers, (2) expanding stroke research core services and user numbers, and (3) continuing
the transition to sustain these resources through a user-based funding model for services at WVU.

Public health relevance
Project Narrative West Virginia (WV) ranks among the worst states in most indicators of health outcome, including stroke prevalence and its co-morbid conditions. To address these issues, the WVU Stroke CoBRE will continue to conduct basic and translational research to decrease morbidity and mortality related to stroke through improved understanding of pathophysiological mechanism(s) of stroke. This will be achieved through the development of stroke researchers at WVU by mentored research training and the expansion of cutting-edge research core facilities.